Differential Regulation and Roles of A-type Lamins in Early G1

Summary
Lamins A, C, B1 and B2 form nuclear intermediate filaments as major components of the dynamic genome-
associated nucleoskeleton. Lamins associate with nuclear envelope (NE) membrane proteins, together forming
nuclear ‘lamina’ networks. Lamins and key partners (LEM-domain proteins and BANF1) are essential during
exit from mitosis to ensure that chromosomes are coalesced, captured and properly organized within the
daughter nucleus. During interphase, nuclear lamina networks have fascinating roles in the higher-order
architecture of transcriptionally-inactive regions of the genome (heterochromatin). Silent regions of each
chromosome, known as Lamina Associated Domains (LADs), are typically located near the NE. There are
clear correlations between LAD organization, epigenomic regulation, and the functional three-dimensional (3D)
folding of the genome. A-type lamins (encoded by LMNA) have key roles in LAD organization. LMNA gives rise
to two major somatic isoforms, lamin A and lamin C, by alternative mRNA splicing. Because the first 566
residues of human lamin A and lamin C are identical, they were long thought to function redundantly. However
new reports show lamin A and lamin C form separate filaments, associate differentially with nuclear pore
complexes and have distinct metabolic phenotypes. We discovered lamin C is required for LADs to associate
with the NE during interphase. Furthermore, lamin C is specifically and strikingly nucleoplasmic during
telophase and early-G1, in stark contrast to lamin A at the nascent NE. Although lamin C is not LAD-
associated in early-G1, we found lamin C associates with LADs as they return to their ‘tethered’ positions at
the NE. We propose lamin C is required for LAD recruitment to the NE, and will test this hypothesis in cells
specifically downregulated for lamin C or lamin A. We can detect distinct yet overlapping proteomes in
unsynchronized cells, comprising emerin and LAP2beta at the nuclear membrane, lamins and soluble partners
(‘connectome’), and a novel LAD-associated proteome. We hypothesize that lamin C specifically interacts with
LADs or LAD-associated proteins during exit from mitosis as a pathway to re-establish the tissue-specific
positioning of silent chromatin (LADs) at the NE. Our models predict distinct proteomes for lamin C vs lamin A
during mitotic exit, distinct changes in the LAD proteome during mitotic exit, and perturbed LAD organization or
LAD recruitment to the NE in cells that lack lamin C during mitotic exit. We will test these models by super-
resolution imaging of lamins and LADs in single cells, directed proteomics, genome organization mapping and
functional studies in cells downregulated for either lamin C, lamin A or validated proteins identified in this work.
This work is expected to fill major gaps in understanding how genome architecture is established after mitosis,
and functional differences between lamin A and lamin C that may also be relevant to the mechanisms of
diseases linked to LMNA.

Public health relevance
Project Narrative Mutation or misregulation of lamin A and lamin C, both encoded by the LMNA gene, are linked to many diseases including cardiomyopathy, lipodystrophy, muscular dystrophy, insulin resistance, accelerated ‘aging’ and cancer. This study aims to understand how lamin A and lamin C each function during the cell cycle to re-establish the appropriate three-dimensional organization of the genome in each tissue. This fundamental knowledge about their individual roles will help scientists understand how networks of genes are organized or perturbed at a ‘higher level’ and may identify proteins that could be targeted to develop new therapeutics.